Enrichment Program

Project Summary/Abstract - Enrichment Program
The Enrichment Program of the Michigan Diabetes Research Center (MDRC) promotes scientific
interchange and collaboration among investigators from diverse backgrounds and disciplines to accelerate
the pace of research relevant to diabetes, its complications, and related endocrine and metabolic disorders.
The program organizes scientific symposia, diabetes grand rounds, research and clinical conferences, visiting
professorships, and research clubs for MDRC members, their lab, and others interested in diabetes research.
The Enrichment program also organizes training programs for postdoctoral fellows, medical fellows, graduate
students, medical students, and undergraduate students. The goal of the MDRC Enrichment Program is to
enlarge, enlighten, and energize the Center's most important asset, its research base, and to make the MDRC
a catalyst for diabetes research at the University of Michigan, regionally, nationally and internationally.